JAK Inhibition in Down Syndrome

PROJECT SUMMARY.
Trisomy 21 (T21) causes a different disease spectrum in people with Down syndrome (DS), protecting these
individuals from some diseases, while strongly predisposing them to others. For example, >50% of adults with
T21 are affected by one or more autoimmune conditions, including a wide range of immune skin conditions.
Unfortunately, the mechanisms driving this different disease spectrum are poorly understood, which creates a
challenge in the clinical management of DS. We recently discovered that T21 causes consistent activation of the
interferon (IFN) response across diverse cell types, which is likely due to the fact that four of the six IFN receptors
are encoded on chr21. Accordingly, T21 cells are hypersensitive to IFN stimulation, display hyperactivation of
JAK/STAT signaling, and overexpress IFN-Stimulated Genes. Furthermore, dozens of inflammatory cytokines
are dysregulated in people with DS, and T21 drives production of potent neurotoxic metabolites via the IFN-
inducible kynurenine pathway. Therefore, we hypothesize that hyperactivation of IFN signaling drives
immune dysregulation and various pathologies in DS, and that pharmacological inhibition of IFN
signaling could have multidimensional therapeutic benefits in this population. Accordingly, we propose
here to complete a first-in-kind clinical trial for a JAK inhibitor in DS. our Specific Aims are:
1. To define the safety profile of JAK inhibition in people with Down syndrome. We will perform an open-
label Phase II clinical trial for Tofacitinib, a JAK1/3 inhibitor, in people with DS and an active immune skin
condition, with the main primary endpoint being the assessment of safety.
2. To determine the impact of JAK inhibition on the immune dysregulation caused by trisomy 21. Using
blood samples collected during the trial, we will define the impact of JAK inhibition on a) IFN scores derived from
the transcriptome of white blood cells, b) circulating levels of inflammatory cytokines elevated in people with DS,
c) levels of neurotoxic metabolites in the IFN-inducible kynurenine pathway, and d) levels of key autoantibodies
involved in autoimmune thyroid disease and celiac disease, two common co-occurring conditions in DS.
3. To define the impact of JAK inhibition on immune skin conditions in Down syndrome. Using proven
metrics currently employed in clinical trials of JAK inhibitors for immune skin conditions, our main secondary
endpoint will be to determine whether JAK inhibition reduces skin pathology in DS.
4. To characterize the impact of JAK inhibition on cognition and quality of life in Down syndrome. Using
a battery of tests to evaluate cognition in DS, we will explore the impact of JAK inhibition on diverse cognitive
functions. Decreased skin pathology may also affect overall perceived health and enjoyment, as well as have
social implications, which will be measured by quality of life assessments.

Public health relevance
PROJECT NARRATIVE. People with Down syndrome (DS) display profound immune dysregulation, which could have myriad negative impacts on their health, including the development of various immune and neurological disorders. Multiple lines of evidence indicate that hyperactivation of interferon (IFN) signaling drives immune dysregulation in DS. This proposal aims to complete a clinical trial in adults with DS and immune skin conditions, using a pharmacological inhibitor of IFN signaling, which is expected to have multidimensional therapeutic benefits in this population.